Mechanism(s) Underlying Hypotensive Response to ARB/NEP Inhibition

PROJECT SUMMARY
Twenty percent of people in the United States will develop heart failure during their lives. Despite beneficial
effects of angiotensin-converting enzyme (ACE) inhibitors, angiotensin receptor blockers (ARBs), beta blockers,
and mineralocorticoid receptor antagonists on mortality, the five-year life expectancy of a patient with heart failure
is fifty percent. In 2015, the FDA approved LCZ696 (Entresto™), a molecular complex of the ARB valsartan and
sacubitril, a neprilysin (neutral endopeptidase-24.11) inhibitor prodrug, after LCZ696 reduced mortality compared
to enalapril in a randomized clinical trial in patients with heart failure, reduced ejection fraction, and increased
circulating brain natriuretic peptide (BNP) or N-terminal (NT) proBNP. LCZ696 also reduces rehospitalization in
acutely decompensated heart failure. Nevertheless, LCZ696 has been underutilized in clinical practice, and
concerns regarding hypotension have impeded use. The mechanism(s) through which the combined ARB and
neprilysin inhibitor reduces blood pressure are not fully known. Neprilysin degrades many vasoactive peptides
including the natriuretic peptides, angiotensins (Ang) I and II, endothelins, bradykinin, and substance P. In heart
failure patients, LCZ696 increases BNP, a neprilysin substrate, while decreasing the non-neprilysin substrate
NT-proBNP, suggesting that LCZ696 potentiates effects of the natriuretic peptide. On the other hand, natriuretic
peptides are poor substrates for neprilysin compared to bradykinin and substance P, which can have beneficial
effects on blood pressure, diuresis, natriuresis, fibrinolysis and remodeling but also contribute to adverse effects
like hypotension and angioedema. Our research group has extensive experience studying the contribution of
peptides to drugs that inhibit vasopeptidases such as ACE, dipeptidyl peptidase-4 (DPP4), and neprilysin. In this
proposal, we test the overarching hypothesis that bradykinin contributes to vasodilator, blood pressure and renal
effects of combined angiotensin receptor blockade/neprilysin inhibition. In Aim 1, we will test the hypothesis that
LCZ696 potentiates the effects of intra-arterial bradykinin, substance P, or BNP compared to valsartan alone.
We will test this hypothesis in the presence and absence of a DPP4 inhibitor, as it may enhance effects of
neprilysin inhibition. In Aim 2, we will test the hypothesis that endogenous bradykinin contributes to hypotensive,
natriuretic and diuretic effects of LCZ696 during initiation and up-titration in heart failure patients using a
bradykinin B2 receptor antagonist. In Aim 3, we will probe the contribution of endogenous substance P to effects
of LCZ696 using a substance P (NK1) receptor antagonist. In the combined Aims 2 and 3, we will assess
individual patient factors such as race, gender, BNP (measured both by clinical immunoassay and by specific
mass spectrometric assay), and NEP activity that predict blood pressure response to LCZ696. These studies
will provide novel information about the mechanism(s) of action of combined angiotensin receptor blockade and
neprilysin inhibition, and lead to new strategies to minimize adverse effects while maximizing beneficial effects
of this promising new class of drugs for heart failure.

Public health relevance
NARRATIVE Heart failure affects 5.7 million people in the United States, and approximately one-half of patients with heart failure die within five years of diagnosis. A novel drug that combines the heart medicine valsartan (an angiotensin receptor blocker) with a new type of medicine called a neprilysin inhibitor reduces death in patients with heart failure, but its use has been limited by side effects such as low blood pressure and we do not fully understand how it works. The purpose of this grant is to determine whether this combined angiotensin receptor blocker/neprilysin inhibitor acts by increasing the actions of specific chemicals in the body (bradykinin, substance P, and brain natriuretic peptide) so that we can optimize the use of this medication while minimizing side effects and potentially identify new drug strategies to reduce the burden of heart failure.